The Study of the Environment and Alzheimer's disease and related Dementias (SEAD)

PROJECT SUMMARY
The rising prevalence of Alzheimer's disease and related dementias (ADRD) is a major public health and
clinical challenge in the United States. Identification of ADRD causes to inform prevention and policy is the
most efficient way to address these challenges. Most research to date has focused on identifying genetic
causes of ADRD, however, recent population-scale studies have shown that environmental exposures, such as
lead and cadmium, also contribute to ADRD risk and etiology. Initial findings on environmental factors linked to
ADRD risk is promising, but human evidence is limited. A wide range of environmental exposures (exposome)
have never been evaluated systematically in relation to incident ADRD. While there is a growing demand to
predict future risk for ADRS more precisely, the role of exposomic data in improving ADRD risk prediction has
never been evaluated. To address these gaps, we propose a prospective cohort study by capitalizing on
existing large-scale, United States nationally representative, multi-ethnic population-based data. The National
Health and Nutrition Examination Survey (NHANES, from 1998-2010, n>15,000) has a variety of
environmental chemical exposure measurements, behavioral risk factors, and clinical phenotypes, and when
linked to Medicare data, provides up to 25 years of incident ADRD. We aim to (1) conduct a biologic
hypothesis-based approach to test the associations of chronic exposure to lead and cadmium with incident
ADRD; (2) conduct a data-driven environment-wide association study to systematically evaluate a wide-range
of environmental toxicants with incident ADRD; and (3) develop and validate an exposome-based risk
prediction model for ADRD using machine learning methods. The proposed study will advance scientific
understanding on how modifiable and currently ubiquitous environmental neurotoxicants can lead to the
development of ADRD. This study assesses the exposome to improve prediction of future disease risk and
define vulnerable populations more precisely. This research will highlight individual-level and population-level
interventions (i.e. precision health) to effectively prevent or reduce the risk of ADRD in the US population.

Public health relevance
PROJECT NARRATIVE The proposed study is relevant to public health and precision health because comprehensive evaluation of a wide range of modifiable environmental exposures, including the currently ubiquitous environmental neurotoxicants lead and cadmium, will advance scientific understanding on the etiology of Alzheimer's disease and related dementias (ADRD) and inform individual-level and population-level interventions to effectively prevent or reduce the burden of ADRD. The proposed study is directly responsive to the 2018 National Institute on Aging AD Research Summit recommendations related to Understanding the Impact of the Environment to Advance Disease Prevention and Enabling Precision Medicine Research for AD/ADRD, and to the research goal of NOT-AG-18-053, Enabling precision medicine for AD/ADRD through deep molecular phenotyping.